DIETARY PROTEIN RESTRICTION EFFECT ON PROTEIN/FUEL METABOLISM IN TYPE 1 DM

To investigate the effects of dietary protein restriction on whole-body protein metabolism, on glucose and fat metabolism and on exercise capacity.